Cell-free formation, visualization and study of inflammasomes in real-time with optical tweezers and confocal fluorescence microscopy

PROJECT SUMMARY/ABSTRACT. Inflammation is the primary response of the innate immune system to fight
infection. Its dysregulation leads to chronic inflammation, a major cause of life-threatening diseases. The onset
of inflammation depends on the intracellular assembly of multiprotein complexes known as inflammasomes,
which form upon the presence of harmful substances by oligomerization of multiple copies of three proteins: -
sensors that react upon danger signals derived from pathogens or damaged tissue; - procaspase-1 that activates
inflammatory cytokines; - the adaptor ASC that functions as a molecular glue by connecting sensor and
procaspase-1 molecules. Studying the molecular mechanisms that govern inflammasome assembly is
challenging due to its dynamic nature and the strong tendency of inflammasome-related proteins to self-
associate. These challenges limit our understanding of inflammasome assembly. Specifically, the AIM2-ASC
inflammasome plays a critical role in the innate immune system against invading pathogens as the AIM2 sensor
is capable of detecting foreign DNA. Despite extensive studies on the operating mode of the AIM2-ASC
inflammasome, the interplay between AIM2, ASC and DNA in inflammasome formation is not fully understood.
Particularly, the kinetic parameters involved in AIM2-ASC inflammasome assembly are not known and a
knowledge gap exists regarding the molecular bases of AIM2 regulation. Filling these gaps will facilitate
identifying molecular interventions for the manipulation of inflammasomes. Single-molecule techniques require
sub-nanomolar protein concentrations thus enabling kinetic studies on inflammasome assembly before massive
oligomerization occurs. In particular, optical tweezers can leverage AIM2-DNA binding and allow full mechanical
control of the single DNA molecule. By combining optical tweezers, confocal fluorescence microscopy for real-
time visualization and microfluidics for stepwise addition of inflammasome components, this proposal aims at
forming and visualizing in a cell-free system and in real-time the AIM2-ASC inflammasome. Evidence is
presented on the application of this strategy showing real-time assembly of AIM2 oligomers stochastically bound
to a single DNA molecule tethered by two optically trapped beads. These promising results will be capitalized to
determine the concerted roles of full-length ASC and AIM2 in inflammasome assembly (aim 1) and to establish
the mechanism of action of a natural inhibitor of AIM2 on inflammasome regulation (aim 2). The overarching
significance of the project is to obtain information on the mechanisms of inflammasome activation and regulation
by overcoming current limitations using the proposed strategy: a) providing unknown information on the kinetics
and assembly of the AIM2-ASC inflammasome; b) setting the grounds for the extension to other inflammasomes
to obtain comprehensive relational data on inflammasome operating modes; c) testing inflammasome inhibitors
to gain in-depth knowledge on their function at the molecular level; d) facilitating the design of molecular models
of disease resulting from excessive inflammasome activation.

Public health relevance
PROJECT NARRATIVE. Inflammasomes are multiprotein complexes that trigger the inflammatory response by sensing danger signals from pathogens and tissue damage. Identifying the factors that control inflammasome assembly and inhibition is critical to address chronic inflammation, which is the culprit of a myriad of human diseases such as atherosclerosis, chronic obstructive pulmonary disease, rheumatoid arthritis, diabetes, cancer and neurological disorders. This project is relevant to NIH’s mission because it proposes and tests a strategy to assembly, visualize and study inflammasomes in real-time and in a cell-free environment that enables control of the protein components and their inhibitors; thus, providing a unique tool to determine the factors governing inflammasome formation and regulation that can help in the design and improvement of therapeutic targets to inhibit inflammation.